MICROTUBULE DYNAMICS IN YEAST

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Odde lab (Univ. Minnesota) is interested in understanding the mitotic spindle in yeast at the level of interplay of motor function and microtubule dynamics such that the can mathematical model mitotic spindles. Their initial modeling work is presented in (Gardner M.K. et al. (2005) Tension-dependent regulation of microtubule dynamics at kinetochores can explain metaphase congression in yeast. Mol Biol Cell. 16:3764-3775.). To build this mathematical model they used previous 3D ultrastructural data on yeast mitotic spindles from the Boulder Laboratory (Winey, M., et al. (1995) Three-dimensional ultrastructural analysis of the Saccharomyces cerevisiae mitotic spindle. J. Cell Biol. 129:1601-1616.). To expand their modeling and to test the model by using it to predict the behavior of spindles in yeast strains mutant in various spindle components, Dave Odde has arranged a collaboration between his group (mathematical modeling) and that of Kerry Bloom (Univ. North Carolina - Chapel Hill, live-cell imaging) and Mark Winey and the Boulder Lab for the 3D Structure of Cells (EM tomography). Thus far, we have revisited wild-type spindle structure using tomography to confirm the previous results based on reconstruction from serial thin sections and to serve as controls for the analysis of mutants. We have also been collecting datasets and modeling spindles from a mutant strain lacking the CIN8 kinesin-like motor, which are very interesting. This work is proving very fruitful and may lead to a manuscript this year.